Sodium channel mutations as a possible cause for primary dysautonomia

PROJECT SUMMARY
Primary Dysautonomia (PD), distinct from the entity called familial dysautonomia, is a multifactorial condition
that runs in families in which the autonomic nervous system (ANS) does not function correctly leading to a
range of disabling disease symptoms. Despite the known fact that PD exhibits Mendelian inheritance patterns,
underlying genetic origins have not been identified. Treatments are solely based on alleviating symptomatology
and there is no rationale for effectuating a cure. To help fill this knowledge gap and start identifying contributing
factors to PD, we closely followed sixty-nine families with a dominant Mendelian inheritance pattern of multiple
shared symptoms including (i) chronic orthostatic intolerance, (ii) chronic fatigue, (iii) primary focal
hyperhidrosis, (iv) chronic itch, and (v) generalized anxiety. We initiated whole-exome sequencing (WES) of
the probands in these families with resulting data suggesting a causal relationship between PD and an
autosomal dominant inheritance pattern of mutations in genes encoding voltage-gated sodium (NaV) channels.
This outcome is strengthened by the fact that we have treated family members with NaV channel modulators
which resolved many of their complaints. Based on preliminary results, we hypothesize that what appears to
pathophysiologically link diffuse autonomic symptoms, is a disease model in which NaV channel mutations can
transform the ANS into an oversensitive nervous system that over time develops incapacitating and persistent
disease. To start investigating the involvement of NaV channel mutations in PD, we devised a strategy to help
elucidate the link between our targets and anomalous activation of the sympathetic nervous system in patients.
Our approach will culminate in the creation of a validated animal model with autonomic dysfunction in which
human therapeutics can be tested. Successful completion will provide new insights into genetic causes of PD,
a vital step towards understanding the multifactorial nature of this disorder.

Public health relevance
NARRATIVE Primary Dysautonomia (PD) is a condition in which the autonomic nervous system does not function correctly leading to disabling and pervasive disease. To start investigating the pathogenesis of PD, we initiated a large- scale exome sequencing project consisting of an unprecedented pool of patients and identified mutations in voltage-gated sodium channels as clinically relevant. To probe the involvement of these genes in autonomic dysfunction and PD, we will create robust animal models in which therapeutics can be tested, and by doing so, we expect to generate a first glimpse into possible causes of PD.